Mech. of Transcriptional Regulation in Activated T-cells

The T-cell Transcription Regulation Group applies transcriptional approaches to understanding how molecular signaling influences gene regulation in mammalian cells. We use T-cells and the process of T-cell activation as a model system. The work and progress in the group over the past year can be defined in 3 major categories:I.Profiling of Transcriptional TargetsII.Defining kinetic profiles of factor occupancy in vivo using Promoter ArraysI.Profiling of Transcriptional TargetsThis year we have a developed a transcriptional approach termed Profiling of Transcriptional Targets (PTT) to help better define how molecular signaling events are integrated in the nucleus to influence gene transcription. The first element of this approach is a high-throughput transcriptional reporter assay where reporter constructs containing various promoters or other gene regulatory elements are inserted into human T-cells and then challenged with a variety (16 or more) of combinations of mitogenic agents in the presence or absence of numerous (8 or more) pharmacological agents with known or presumed immuno-modulatory activity. As a result, multiple gene regulatory region of specific genes can be assessed under over one hundred (128) conditions. Since this process generates a large volume of "high dimensional" or multivariate data, we have effectively applied the use of several computational methods well suited to the type and volume of this data. These methods include unsupervised neural networks, hierarchical clustering and principal component analysis. By this method, we have been able to determine relationships between specific gene regulatory elements and promoter in terms of how they respond to different mitogens and pharmacological agents. This approach has enabled us to identify an operational signaling pathway in activated T-cells that responds to the addition of IGF-1 by up-regulating signaling through a PI3-kinase dependent pathway to exert reciprocal control over NF-kappa B and AP-1 transcriptional activity. Phylogenetic footprinting of gene regulatory elements that respond to IGF-1 reveals that potentially many genes that influence immune cell function or potential targets for IGF-1 regulation. Preliminary gene expression studies using focussed cDNA immunoarrays confirm this.Recent expansion of this technique to examine the transcriptional targeting of thalidomide analogues and histone deacetylase inhibitors has reveal very selective molecular signal profiles of each of these drugs. In order to retrieve transcriptional information that more closely resembles the in vivo regulation of target genes we have adapted PTT to be used with nuclear run-on experiments. This approach combines the molecular specificity of the nuclear run-on technique with micro-array. This process allows the simultaneous assessment of nuclear pre-mRNA populations in comparison to the steady state pool of cytoplasmic RNA. Thus changes in gene expression can be examined at both the level of transcriptional regulation and transcript stabilization.II.Kinetic Profiling of Promoter Occupancy in in vivoWe have adapted the chromatin immunoprecipitation assay (ChIP) for highthroughput analysis by combining it with microarray technology (ChIP to chip). This allows us to profile the kinetic association of transcription factors and other co-regulatory elements with tens to potentially thousands of different promoter regions simultaneously. In collaboration with the NCI microarray facility and using a microarray printed with genomic PCR fragments containing the promoter regions of known genes, we have been analyzing the kinetic association of the co-activator protein p300 with multiple gene promoter regions in activated T-cells. Measurements are taken over 15 minute intervals following stimulation of the T-cells. The resulting data is a series of kinetic occupancy curves or retentions times that profile the changing interactions of p300 with each gene on the array. The use of these genomic "Promoter Arrays" reveals that genes and their promoters can be classified by the manner in which p300 associates with them under a particular stimulus. Comparing the promoter regions of these classes using bioinformatics software reveals patterns of sequences composition and structure that has predictive value in determining their functional requirements for p300. We have currently organized a multi-institutional pilot promoter array study (pPROMP) under the supervision of the Cellular, Molecular and Developmental Biology Faculty of CCR. The study is a collaboration between CCR, the Cancer Genotype Facility, CGAP, National Institute on Aging, the Bioinformatic Group at Ohio State University to provide an 1000+ genomic promoter array for ChIP to Chip studies. Primer sets designed and used for the production of PCR fragments for printing onto arrays at NCI and NIA will be provided to CGF/CGAP for screening regulatory SNPs in several populations. This array will then become a source of the production of several orthologous data sets that will provide basic, clinical and population scientists access to empirically correlated information about promoter structure and function.